Understanding small molecule modulation of splicing for Huntington's disease therapy

Summary:
Small molecule splicing modulators have emerged recently as exciting new approaches to efficiently modulate
protein levels in genetic diseases that affected the CNS. One such compound, risdiplam, is orally bioavailable
with excellent CNS distribution and has been approved by the FDA in 2020 for the treatment of Spinal
Muscular Atrophy (SMA). This approval has generated tremendous excitement about using small molecule
splicing modulators as a new way to reduce huntingtin (HTT) protein levels in Huntington’s disease (HD) by
inducing the inclusion of a “poison” exon in HTT, leading to non-sense mediated decay of its mRNA. Although
branaplam, a splicing modulator developed by Novartis, has recently been suspended in phase 2 clinical trial
for HD due to peripheral neuropathy, PTC Therapeutics was able to identify a different class of splicing
modulator that induces the same “poison” exon inclusion but enters the CNS much better, potentially avoiding
peripheral neuropathy. An analog in this class is currently in phase 2 clinical trial. These results highlight the
potential of splicing modulators for HD therapy, as well as the critical need for understanding the mechanism of
action of these modulators to facilitate compound optimization and overcome the many hurdles in the journey
of these compounds in becoming an FDA-approved drug. Despite the spectacular success of these splicing
modulators in treating CNS disease such as SMA, the mechanism of action of these compounds remains
unknown. We propose to evaluate the feasibility of determining the mechanism of action of these compounds
using a combination of cyro-EM structural determination and biochemical approaches. Support from this R21
grant will allow us to work out the challenges and develop a tool to understand the mechanism of action of
these modulators. This will not only be a huge facilitator for the development of these modulators into HD
therapeutics, but also will potentially benefit the development of these compounds for many other neurological
diseases in the future.

Public health relevance
Small molecule splicing modulators have recently been shown to effectively lower Huntingtin protein level in mouse models and one representative member is currently in phase 2 clinical trial. Our goal in this project is to explore the feasibility of determining the mechanism of action of these small molecules with their target U1 snRNP and RNA complex. These results will be critical for guiding the optimization of these compounds to obtain drugs for the treatment of Huntington’s Disease.